Career Enhancement Program

PROJECT SUMMARY/ABSTRACT: Career Enhancement Program
The goal of the Vanderbilt-Ingram Cancer Center (VICC) SPORE in Gastrointestinal (GI) Cancer Career
Enhancement Program (CEP) is to provide individuals with the training, mentorship, and collaborative
interactions necessary for them to have successful and independent careers in translational GI cancer
research. We have a multi-faceted and multi-layered plan for selecting and mentoring exceptional physicians
and scientists to advance careers in GI cancer research and care. The goal is to provide CEP recipients with
both an integrated, multi-disciplinary environment and an individualized mentored research experience that
facilitate the development of outstanding research programs and successful academic careers.

Public health relevance
PROJECT NARRATIVE: Career Enhancement Program The goal of the Vanderbilt-Ingram Cancer Center SPORE in Gastrointestinal Cancer Career Enhancement Program (CEP) is to provide individuals with the training, mentorship, and collaborative interactions necessary for them to have successful and independent careers in translational gastrointestinal cancer research.